MEDICAL WRITING CONSULTING AND DRUG DOSSIER DEVELOPMENT SUPPORT SERVICES

MEDICAL WRITING CONSULTING AND DRUG DOSSIER DEVELOPMENT SUPPORT SERVICES- NIH HEAL Initiative- “This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”